Cross-Species comparison of cholinergic neuromodulation in mice and primates

Project Summary / Abstract
The brain continuously regulates its internal states in order to efficiently and flexibly interact with the environment.
Brain states vary at a global scale due to changes in arousal, whereas local changes are typically observed
during selective attention. Although arousal and attention operate at different spatial scales, they have similar
physiological signatures. However, the major limitation of our understanding of the impact of brain states on neuronal
circuits is the fact that arousal and attention have mostly been studied separately and in different species.
Indeed, despite clear similarities between neural correlates of arousal in the mouse and attention in the primate,
research on brain states in the two species has proceeded largely in parallel, with very few direct collaborations
between primate and rodent labs. Therefore, whether and how the mechanisms regulating brain states on different
spatial scales intersect to jointly influence neuronal function and behavior is unknown. Furthermore, with
few exceptions, attention and arousal have been typically examined in one brain area at a time, hence precluding
our understanding of the coordination of brain states at global and local spatial scales, their neural mechanisms,
and their influence on behavioral performance. Here, we propose to develop several technical capabilities that
will allow us to study multiple features of brain state changes across quiescence, arousal, and attention in mice
and monkeys. We will develop a workflow for performing large-scale electrophysiological and optical recordings
from multiple cortical areas relevant for visual behavior, establish a complementary behavioral paradigm in both
species, and validate an optogenetic approach to silencing feedback. These capabilities will allow us to test three
central hypotheses in a subsequent R01: (1) brain state changes in the mouse are a subset of changes in the
primate, with similar underlying mechanisms but different spatial scales (Aim 1 ); (2) selective attention is built on
top of mechanisms that mediate fast changes in global arousal (Aim 2), and (3) feedback from higher areas onto
specific neural cell types mediates selective attention and is gated by global neuromodulation (Aim 3). These
experiments a will generate a potentially transformative multi-modal dataset for understanding the mechanisms
of attention and arousal at single cell resolution, which will also advance our understanding of dysfunctional brain
states and their impact on neurological disorders.

Public health relevance
Project Narrative The state of the brain fluctuates thousands of times during the course of the day, and these changes may be global across the brain during changes in arousal, or localized during attention. Despite the fact that these changes are ubiquitous and influence how we interact with the environment, several technical and conceptual limitations of previous studies have prevented our mechanistic understanding of the effects of brain state on behavior across species. Here, we propose to optimize and validate several recent technical innovations in dissecting neural circuits, now available across species, to study multiple features of brain state changes across quiescence, arousal, and attention in mice and monkeys.